22nd Biennial Conference of the International Society for Research in Human Milk and Lactation (ISRHML)

The proposed scientific conference is organized by the International Society for Research in Human Milk and
Lactation (ISRHML) Conference and entitled, “22nd ISRHML International Conference on Human Milk and
Lactation Research: Advancing Science, Fostering Inclusivity, Shaping the Future” will take place on December
9-13, 2024, in Charleston, South Carolina. This conference will bring together researchers, clinicians, and
healthcare professionals from diverse backgrounds and geographical regions around the globe, creating a
dynamic platform for scientific exchange, education, and collaboration. The conference’s primary focus is to
promote scientific excellence in the field of human milk and lactation research. Specifically, the Aims of the
Conference are threefold: (1) Foster an inclusive exchange of scientific knowledge on the biology of human milk
and lactation; (2) Advance cutting-edge research on the health effects of human milk and lactation; and (3)
Translate basic science research into clinical practice and refine dissemination strategies. Distinguished from
other conferences, this event is specifically designed to emphasize specialized research in human milk biology
and composition and translating scientific discoveries from laboratory research to clinical practice. The
conference will adhere to WHO code guidelines and offer CME/CE accreditation.
Through this R13 application, we will offer trainee travel awards, virtual participation options, and
accommodations for individuals with disabilities, ensuring that the conference is accessible to a broad audience.
Beyond the conference, we are committed to evaluating the success of our inclusion, diversity, equity, and access
(IDEA) efforts. Metrics include representation, attendee feedback, post-conference collaborations, longitudinal
assessments, and comparisons to established benchmarks. These evaluations will inform our strategies for
future conferences and contribute to creating a lasting impact on the scientific community. We anticipate sharing
of breakthroughs, fostering new collaborations, and shared discoveries that will shape the trajectory of research
in this vital field. Our Aims collectively underscore our commitment as a Society to advancing the scientific
exploration of human milk and lactation, while emphasizing the global reach and inclusivity of our conference.
By aligning our objectives with the goals of the NIH, through this planned conference, we aim to advance
scientific knowledge, promote health equity, and ensure that research in human milk and lactation contributes
significantly to the well-being of people worldwide.

Public health relevance
Lay Abstract The 2024 ISRHML Conference, featuring expert speakers, aims to explore breast milk's impact on maternal and infant health and the latest -omic and breastfeeding technologies is a hybrid event over five days, with 200 participants that prioritizes educating trainees globally. Topics include climate change's effect on breastfeeding, genomic aspects, breastfeeding technologies, and health advancements from breast milk research. This event advances understanding of breast milk's role in both short- and long-term maternal and infant health, fostering access, equity, inclusion, and diversity in the process.